Roles of Macrophages in Cisplatin-induced Hearing Loss

PROJECT SUMMARY (See instructions):
Cisplatin, a widely used chemotherapeutic drug, is toxic to mechanosensory hair cells in the inner ear,
resulting in permanent hearing loss in up to 60% of cancer patients. However, limited treatment strategies
are available that are effective in treating cisplatin-induced hearing loss without reducing the antitumor
efficacy of cisplatin, highlighting the need for continued development of therapies. Macrophages, the major
resident immune cells in the cochlea, are important drivers of inflammatory and tissue repair responses.
Specifically, perivascular macrophages are closely associated with the blood-labyrinth barrier (BLB) in the
inner ear and regulate BLB permeability. Macrophage ablation using Pexidartinib (PLX3397) has been shown
to provide complete protection against cisplatin-induced hearing loss and reduce cisplatin entry into the inner
ear. Given that cisplatin is known to enter the inner ear through the BLB, this suggests that macrophages
may play a role in BLB breakdown in response to cisplatin. The goal of this proposal is to identify the
mechanism(s) by which macrophages regulate BLB permeability in response to cisplatin-induced
ototoxicity in both non-tumor-bearing and tumor-bearing mice, while also determining whether
Pexidartinib (PLX3397) compromises the antitumor efficacy of cisplatin. Aim 1A will investigate the
contribution of VEGF-A-Flt1 signaling to macrophage-mediated regulation of BLB permeability following
cisplatin treatment, using conditional knockout mice that disrupt this pathway. BLB permeability will be
assessed through tracer assays, junctional protein expression will be evaluated, and cisplatin levels will be
quantified in inner ear tissues to determine the extent of drug accumulation. Aim 1B will identify additional
soluble factors that contribute to regulation of BLB permeability within specific cell types of the stria
vascularis. Single-nucleus RNA sequencing will be employed to characterize transcriptional changes induced
by cisplatin exposure. Aim 2 will address whether macrophage ablation using Pexidartinib (PLX3397)
regulates BLB permeability while preserving the antitumor efficacy of cisplatin, using a newly developed
tumor-bearing mouse model that exhibits cisplatin-induced hearing loss. Findings from this study will inform
the rational design of treatment strategies to prevent cisplatin-induced ototoxicity by regulating BLB
permeability and controlling drug delivery into the inner ear. Additionally, the results will provide clinical
insights into the potential repurposing of PLX3397 as an otoprotective agent for patients undergoing cisplatin-based chemotherapy.

Public health relevance
RELEVANCE (See instructions): Cisplatin is a widely used and effective anti-cancer drug, but it can cause permanent hearing loss. The research proposed in this application will characterize how macrophages influence drug entry into the inner ear by regulating the permeability of the blood-labyrinth barrier. Ultimately, these findings will provide a rational approach to developing therapies aimed at preventing cisplatin from entering the inner ear, thereby protecting the hearing of cancer patients undergoing cisplatin-based chemotherapy.